Integration and Validation of Single-Cell Neuronal and Immune Molecular Responses in SUD and HIV

Abstract
HIV-associated neurocognitive disorders (HAND), substance use disorders (SUD), Alzheimer's Disease (AD),
and neuropsychiatric conditions share converging mechanisms of neuroinflammation, immune dysregulation,
synaptic dysfunction, and neuronal injury that accelerate cognitive decline. Moreover, SUD and
neuropsychiatric disorders co-occur at higher frequencies in persons living with HIV (PLWH) than in the
non-HIV population, making it difficult to untangle the influence of these shared genetic mechanisms on
progression of the diseases. The Single Cell Opioid Responses in the Context of HIV (SCORCH) consortium
aims to address this complex interplay between HIV, substance use disorders (SUDs), and neuropsychiatric
conditions. Leveraging the extensive data from SCORCH, PsychENCODE, and Alzheimer’s Disease (AD)
datasets, our proposal aims to uncover the genetic and molecular mechanisms driving the interactions
between HIV, neuropsychiatric, and neurodegenerative conditions. We employ advanced computational
techniques to identify differences in gene expression across disorders, with a focus on identifying shared and
distinct drivers of HIV and SUD impact on psychiatric genes and pathways (HAND), and their interplay with
Psychiatric disorders (Psych) and dementia/cognitive impairment (DCI). In Aim 1, we leverage single-cell
transcriptomics and spatial datasets with advanced machine learning algorithms including contextualized
learning, module analysis, and cell-projected phenotypes to discover shared and distinct
differentially-expressed genes (DEGs), pathways, modules, and cell types underlying HAND-Psych-DCI. In
Aim 2 we also leverage single-cell epigenomics and genetics datasets to infer cell-cell-communication
between microglia and neuronal cells, gene-regulatory networks, upstream regulators/TFs, cell-cell
communication, and causal drivers, and create a public resource and interactive website for broad data
dissemination of all primary, secondary, and tertiary analyses and results for the broader scientific community.
In Aim 3 we perform experimental characterization and mechanistic testing in vivo. We develop viral tools for
targeting and tracing cholinergic neurons in the mouse basal nucleus of Meynert (BNM), investigate the effects
of bidirectional modulation using DREADDs in these neurons, and assess the functional implications of
HIV-associated inflammatory signaling. The successful execution of our study will elucidate clinically relevant
connections between HIV, neuropsychiatric, and neurodegenerative disorders by examining single-cell
transcriptional changes in an integrated experimental and computational framework. This approach enables us
to dissect distinct molecular pathways across brain regions and cell types, providing a deeper understanding of
the unique and shared mechanisms underlying these conditions. The insights gained will be crucial in guiding
the development of new therapeutic strategies.

Public health relevance
Narrative HIV-associated neurocognitive disorders (HAND), substance use disorders (SUD), Alzheimer's Disease (AD), and neuropsychiatric conditions share converging mechanisms of neuroinflammation, immune dysregulation, synaptic dysfunction, and neuronal injury that accelerate cognitive decline. To uncover their shared and distinct mechanistic underpinnings at single-cell resolution, we leverage data from SCORCH, PsychENCODE, and AD datasets, including thousands of post-mortem human single-cell brain datasets generated in our lab, integrating single-cell transcriptomic, epigenomic, and spatial information across ~20 million cells to identify key cell types, genes, pathways, regulators, and networks that underlie SUD and HIV interactions and their resulting cognitive symptoms. We validate our findings experimentally through in vivo studies of cholinergic neurons in the mouse, specifically assessing the bidirectional impact of these neurons in cognition and reward, and their dysfunction in HIV-associated neuroinflammation.